Age-related changes to the senescence associated secretory phenotype of thyroid tissue in papillary thyroid carcinoma

Project Summary & Abstract
Advanced age is associated with compromised outcomes in differentiated thyroid cancer. This observation
suggests that there is a biologic change due to aging that causes the poorer prognosis for the older adult.
Studies of the aging thyroid have reported that detrimental immune modulation and cellular senescence
contribute to thyroid diseases in the older adult, both of which have been implicated in the progression of
malignancies. Aging is associated with a state of chronic inflammation due to the secretion of inflammatory
proteins collectively known as the senescence-associated secretory phenotype (SASP) from senescent
cells. There is a critical need to understand the connection between immune modulation and cellular
senescence via the SASP and tumor progression in older adult patients. Our long-term goal is to better
characterize the role of age-associated immune modulation in the development and progression of
papillary thyroid carcinoma (PTC) in the older adult population. The overall objective of this proposed
study is to elucidate the interplay of age and SASP production in thyroid tissue to guide personalized
management of older adult patients with PTC. Our central hypothesis is that advanced age induces an
SASP transcriptome in senescent thyroid fibroblasts that leads to enhanced progression of PTC. This
hypothesis will be tested using publicly available large RNA sequencing datasets and single-cell RNA
sequencing technology to pursue two specific aims: (1) to identify the contribution of advanced age to the
SASP in thyroid tissue and (2) to identify alterations in the SASP transcriptome of aged thyroid fibroblasts
due to local and locoregionally advanced PTC. This project is innovative because it is the first study to
characterize the contribution of age to SASP production in normal thyroid tissue and leverage
deconvolution techniques to isolate senescent thyroid fibroblasts of older adults to examine how the SASP
contributes to PTC progression. The proposed research will establish validity for the unique SASP
transcriptome in thyroid tissue and thyroid disease and lay the groundwork for further mechanistic studies
into the role of older adult immune modulation in thyroid diseases.

Public health relevance
Project Narrative Older thyroid cancer patients are more likely to present with advanced tumor size, locoregionally aggressive disease, and compromised outcomes, irrespective of disease stage. Nevertheless, the treatment for thyroid cancer remains age agnostic, with little investigation of treatment options for the older adult patient. The proposed research is relevant to public health because it will explore the mechanisms by which age-associated immune modulation lead to the development and progression of papillary thyroid carcinoma to aid in the identification of personalized approaches for treatment in older adult patients.